Core 4 Sali Echeverria

THE HARC CENTER: HIV ACCESSORY AND REGULATORY COMPLEXES
COMPUTATIONAL CORE
SUMMARY
The overall goal of the Computational Core is to facilitate the analysis and interpretation of multiple data types
across Projects and Cores to characterize the cellular networks, proteins, and protein complexes that influence
HIV replication and latency. We will employ existing bioinformatics and systems biology approaches, as well as
develop new methods to facilitate the unification of mechanistic and structural details with network biology, with
a strong emphasis on the analysis and integration of data derived from proteomics, genetics, and structural
biology approaches. Specifically, we will provide the tools to identify interactions of endogenous proviral and
antiviral HIV-host protein complexes that have been structurally and functionally characterized by the
Proteomics, Genetics, and Structural Biology Cores. This includes datasets from affinity purification mass
spectrometry (AP-MS), native mass spectrometry (nMS), cross-linking mass spectrometry (XL-MS),
hydrogen/deuterium exchange mass spectrometry (H/DX-MS), systematic genome editing by CRISPR-Cas9,
deep mutational scanning (DMS), and cryo-electron microscopy (cryo-EM). These datasets will be analyzed
separately as well as jointly, followed by visualization to gain a deeper understanding of the functional pathways
that are modulated during HIV infection. Finally, we will determine the structures of HIV-human protein
complexes by an integrative approach using various proteomics, genetics, structural, and biochemical data.
Integrative structure determination will be performed using the open-source Integrative Modeling Platform (IMP)
package developed in the Sali lab (Core Lead). We will initially focus on protein complexes containing human or
simian A3Gs, and HIV-1 Vif, Rev, and Tat, followed by structure determination of HIV-human complexes
identified from CD4+ T cells and structurally interrogated by the Proteomics Core.